HORMONAL REGULATION OF PLASMA GLUCOSE

The plasma glucose level is controlled by hormones. Insulin decreases glucose and epinephrine increases glucose. This protocol exposes first year medical students to this regulation and to clinical research.